Ototoxicity-associated Mutations Following Antiretroviral Exposure

Though preclinical studies indicate that HIV medications harm hearing and magnify the risk of ototoxic hearing
loss, there has been no investigation of the impact of these drugs, and their resulting mitochondrial damage, on
hearing in people taking these medications for the management or prevention of HIV. As such, there is a critical
need for knowledge of the effects of HIV and antiretroviral therapy (ART) on mitochondrial DNA (mtDNA) in
humans and the relationship between these mitochondrial mutations and auditory status. My long-term career
goal is to become a VA Career Scientist dedicated to preventing or alleviating the impacts of auditory impairment
in Veterans through studies that combine hearing loss epidemiology, mechanisms and modeling. My immediate
goals for this proposed CDA are to gain specific training in statistical modeling, genetics, and human auditory
physiology that will enable me to forecast ototoxic-acquired hearing loss in individual-patients and minimize the
auditory dysfunction resulting from these exposures. An additional goal for this CDA is to generate publications
and pilot data to support a VA Merit Review and/or NIH R01 award. My overall objective for this proposed CDA
research is to identify genetic and clinical markers of patients who are at high risk for antiretroviral-induced
hearing loss and effective alternatives to reduce and prevent that damage. The central hypothesis is that specific
ART drugs cause auditory dysfunction and mtDNA damage. The rationale for the proposed research is that once
ART drugs causing these mutations have been identified, treatment recommendations can be modified to reduce
and prevent ototoxic hearing loss for people taking antiretroviral medications. To test my central hypothesis, the
research team will pursue two specific aims: 1) Classify risk for mutations of mtDNA by ART exposure regimen;
and 2) [Estimate ART-related risk for auditory dysfunction] among patients exposed to ART. For this first aim,
[we will use data available from the Million Veteran Program (MVP) create a] cohort of patients receiving ART:
1) for the management of HIV and 2) for pre-exposure prophylaxis (PrEP) to prevent HIV infection. [Using clinical
and genetic information available in the MVP data core,] the research team will identify relationships between
different ART combinations and three mtDNA mutations that have been associated with increased ototoxicity.
For the second aim, a predictive machine learning model will be created for antiretroviral-induced ototoxicity.
This model will be trained and tested on data from a cross-sectional cohort to identify key predictors of auditory
dysfunction. This model-driven approach has the advantage of detecting changes in auditory performance with
greater accuracy and speed than traditional hearing screening approaches and can be used to forecast hearing
loss due to a hypothetical exposure before the exposure occurs. Additionally, access to this large national cohort
will provide critical information for a needs assessment of current practices at the interface of HIV and audiologic
care, including most common ART prescriptive patterns and the uptake of audiological services across drug
regimens. The proposed research is significant because it is expected to identify ART regimens used in the
management and prevention of HIV that are less ototoxic and genotoxic overall. Especially given the importance
of the use of ART in stopping the spread of HIV, this research is essential in identifying and proactively reducing
hearing loss, a side effect of treatment that reduces social and emotional well-being and can lead to non-
compliance and the subsequent continued spread of HIV. These studies will provide the basis for a multi-site
study investigating these and other mtDNA mutations in a large prospective cohort which will allow for more
robust development and testing of this predictive model and genetic determinants of hearing loss.

Public health relevance
Studies in animal models show that the antiretroviral medications used to manage or prevent HIV can harm hearing and magnify the risk of ototoxic hearing loss by damaging mitochondrial DNA. Yet there has been no investigation of the impact of these drugs on human hearing. This proposed research is relevant to Veterans’ health because it will clarify the genetic and auditory effects of antiretroviral exposure on Veterans receiving healthcare from the Veterans Health Administration (VA), the largest single provider of HIV care in the United States. Continued use of daily antiretroviral therapy is a cornerstone of VA’s strategies for HIV prevention and management and the US Department of Health and Human Service’s goal to end the HIV epidemic by 2030. Once regimens with the greatest risk of ototoxicity and genotoxicity have been identified, alternative regimens for HIV management and prevention can be implemented that support these public health goals while preserving hearing.